Prevention Research in the Digital Age: Public and Private Partnerships for Sustainable Impact at Scale

Project Summary: The Yale-Griffin Prevention Research Center (Y-G PRC) continues its focus on chronic
disease prevention while expanding its emphasis to Prevention Research in the Digital Age: Public and Private
Partnerships for Sustainable Impact at Scale. The Y-G PRC was founded at a time when health promotion
strategies generally took place at a local level and were limited by physical space and time. During the last 20
years, there has been a tectonic shift in communications, digitally and in cyberspace, with a resulting opportunity
to reach target populations using strategies and a scope that were previously unimaginable. The specific aims for
the Center are to: Advance prevention research with a primary focus on addressing health disparities and
preventing diabetes, obesity and cardio-metabolic disease in underserved communities; Maintain and cultivate
the resources and infrastructure to support a thriving research agenda; Support one core CBPR project; Nurture
and grow a network of collaborations and partnerships; Provide training and ongoing education to public health
students and practitioners, medical residents, collaborators, partner organizations and communities, and staff;
Effectively communicate, disseminate and translate research advances to practice, programs, and policy; and,
Pursue innovative approaches to dissemination and widespread scalability through public and private sector
partnerships. The Y-G PRC's primary research agenda for the upcoming 5-year cycle is to conduct an
Implementation Science Research study assessing the feasibility and pathways for implementation of a virtually-
delivered Diabetes Prevention Program facilitated by community health workers and hospital-based community
nurses to improve behavioral and cardio-metabolic outcomes among low-income individuals at risk for type 2
diabetes. The primary study, Improving Health in Low Income Communities: Virtual Delivery of a Diabetes
Prevention Program Facilitated with Community Care Coordination, will address many of the barriers that
keep low-income populations from successfully participating in evidence-based lifestyle interventions. Working
in two diverse low-income communities, we will apply the Program Impact Pathways and RE-AIM frameworks
to assess implementation processes and evaluate implementation outcomes. Rigorous formative assessments
will guide the project; clinical and behavioral changes, and cost effectiveness will be assessed. This project offers
innovative approaches to understanding and addressing complex health and social conditions among our most
vulnerable populations to improve health and reduce disparities nationally.

Public health relevance
Project Narrative The successful implementation of our project will provide a roadmap for implementation of such interventions in other low-income communities in our region as well as nationally.